CUIMC Calabresi Clinical Oncology Career Development Program

PROJECT SUMMARY/ABSTRACT
This application seeks to establish the Paul Calabresi Career Development Award for Clinical
Oncology (K12) at the Columbia University Irving Medical Center (CUMC) and the Herbert Irving
Comprehensive Cancer Center (HICCC). The proposed program, which will be called the CUIMC
Calabresi Clinical Oncology Career Development Program (CUIMC-K12), will take advantage of the
strong faculties in clinical medicine and basic and population sciences as well as the deep
technologic resources of CUMC and the diverse community of patients it serves. As a Minority
Underserved-NCI Community Oncology Research Program (MU-NCORP) site, we are positioned to
train the next generation of clinician scientists from multiple specialties (Medical Oncology, Radiation
Oncology, Surgical Oncology, Pediatric Oncology, Gynecologic Oncology) to perform translational,
clinical and outcomes research with a health equity lens, emphasizing how diverse differences such
as gender, race and zip code should be considered in preclinical and clinical study design,
recruitment, conduct and analysis. We have chosen 46 of the top mentors at CUIMC, with average
direct costs of grant support per mentor exceeding $1M, including physicians and scientists who are
internationally recognized leaders for their research excellence and outstanding mentoring records. A
core feature of our program is fostering multi-disciplinary cancer research by encouraging a
mentorship team comprised of basic and translational mentors and clinical trial advisors. We will also
include secondary mentors that are junior in nature, designated as ‘Junior Mentors,’ who will function
as near peers to our Scholars and serve as the next generation of primary mentors. The
comprehensive research training environment at CUIMC/HICCC will provide the Calabresi Scholars
the advanced skills necessary to perform state-of-the-art clinical research with the ability to:
1. Perform pre-clinical, therapeutic, translational and population science/cancer care delivery state-
of-the-art clinical research that develops and tests scientific hypotheses with the goal of reducing
the mortality and morbidity of cancer.
2. Design and administer all phases (i.e., pilot/Phase I, II and III) of cancer clinical trials that
prospectively evaluate clinical, biological, patient-reported and economic endpoints.
3. Conduct clinical cancer research in a diverse team setting to expedite and accelerate the
translation of basic and observational research into patient-oriented clinical trials.
4. Consider how diversity should be included and emphasized in clinical study design, recruitment,
conduct and analysis with a goal of reducing health disparities and increasing generalizability.
5. Obtain peer reviewed funding to support careers as independent clinician scientists.

Public health relevance
PROJECT NARRATIVE It has been recognized that there is a deficiency in adequately trained cancer physicians that will grow by 2025. The rapid nature of innovation in cancer research creates added challenges for trained medical, radiation, surgical, pediatric, and gynecologic oncologists who will form the next generation of researchers with backgrounds that support and optimize clinically relevant investigation. The Columbia Paul Calabresi Clinical Oncology Training Program (K12) will provide an ideal setting in which outstanding and comprehensive clinical research training can assure a cadre of future well-trained clinical investigators who will have the greatest impact on cancer care in the United States.